TECHNOLOGY CORE

The goal of the Technology Core is to provide innovative assessment techniques to promote an understanding of the biomechanical, anatomical and physiological influences on balance problems of aging. The facilities involved are established laboratories at the University, including the Human Movement and Balance Laboratory, the Medical Virtual Reality Center, the Jordan Balance Disorders Center, the Magnetic Resonance Imaging Center and the PET Imaging Center. Each of these facilities offers a unique, state of the art capability to study different aspect of balance in older adults, including human movement analysis, vestibular function evaluations, strength testing, assessment of sensory integration capabilities and innovative imaging techniques. The proposed Technology Core will coordinate these established facilities to meet the goals of the Pepper Center. The Specific Aims of the Technology Core are: 1) Provide consultation to investigators about the capabilities and potential use of facilities within the Core, 2) Coordinate and prioritize the utilization of resources within the Core, 3) Develop new technologies and approaches, and, 4) Support the research training mission of the Pepper Center. This Core will be a key contributor to the goals of the proposed Claude Pepper Center to increase understanding of mechanisms underlying alterations in balance among older Americans.